GENES OF HYPERTENSION IN AFRICAN AMERICANS

This project will study African American sibs with both hypertension and hyperlipidemia to identify genetic markers that are associated with either hypertension or physiologic correlates of hypertension.